Translational research training in cardiovascular science

PROJECT SUMMARY/ABSTRACT
Research in cardiovascular science is rapidly progressing, as cardiovascular disease remains the largest cause
of mortality and morbidity in the United States, particularly as the population ages. At the same time, however,
surgeon-scientists have increasing clinical responsibilities which they must meet to fulfill teaching and
reimbursement requirements. All of this occurs in the backdrop of a highly competitive funding environment. Thus,
there is a significant threat to maintaining surgeon-scientists to address the critical issues in vascular biology and
cardiovascular science and provide a translational perspective. With this background, it is clear that proper
training in research in vascular biology and cardiovascular science is critical for those surgeon scientists who will
be the leaders in this field over the next decade(s), by providing them with the tools and knowledge to become
independent scientists. We believe this training program has and will continue to give the next generation of
vascular disease-focused surgeon-scientists an outstanding platform to build from and to launch an independent
career in translational science. The current T32 proposal, “Translational Research Training in Cardiovascular
Science”, provides research training in vascular clinical science and biology. The program provides for one
physician (MD, MD/PhD, DO) trainee per year to choose from one of three distinct tracks: (1) basic
science/translational science; (2) health services/outcomes; or (3) biomedical engineering. A great strength of
the program is the cross fertilization between the three curricula with common elements of training for all
pathways. Training takes place at various locations throughout campus including the North Campus Research
Complex (NCRC), the Biomedical Research laboratories, School of Engineering laboratories, and at the Michigan
Medicine Samuel and Jean Frankel Cardiovascular Center. Faculty for the program come from multiple disciplines
and include funded, committed investigators with strong mentoring track records that are in various disciplines
including Vascular Surgery, Biomedical Engineering, Cardiovascular Medicine, General Surgery, Internal
Medicine, Microbiology and Immunology, Molecular and Integrated Physiology, Pharmacology, and Radiology.
The common thread in this program is the emphasis on the study of vascular biology and cardiovascular science
with the ultimate goal to develop the next generation of physician-scientists in academic vascular biology and
cardiovascular science.

Public health relevance
PROJECT NARRATIVE Surgeon-scientists in training have competing clinical responsibilities but must compete for contentious funding lines, which means that state-of-the art training is critical for producing the best surgeon-scientists. With the aging of the population, the number of patients with cardiovascular disease is markedly increasing. The proposed program, with its overarching focus on vascular biology and three distinct tracks including (1) basic/translational, (2) health sciences and (3) biomedical engineering, under multi-disciplinary preceptor guidance, will produce the next generation of surgeon-scientist leaders who will pave the way to new discoveries in human health.